UA Student Development: Data Warriors Fellowship Program

Data Warriors Fellowship Program Project Summary/Abstract
The UA Data Warriors Fellowship Program is for American Indian and Alaska Native (AI/AN)
graduate students with a concentration in AI/AN medical and public health informatics. It is a
Student Career Enhancement Program in response to the Native American Research Centers
for Health XI and a collaboration with the Inter Tribal Council of Arizona (ITCA) implemented at
the University of Arizona. Graduate students in public health, sociology, informatics or related
degrees participate in a year long paid, specialty training and summer internship with a Tribe or
Tribal Epidemiology Center. The program will train 12 Fellows over the four year period. The
program offers 6 core elements to student success. Upon entry into the program, students are
assessed regarding learning styles, skills and knowledge. An Individual Development plan is
created based on assessments in collaboration with the student’s academic advisor. Required
coursework includes classes in Health Disparities Research, Data Science and Statistics,
Indigenous Data Governance. Students will be mentored in a research project responsive to
health priorities and selected by the Tribal Epidemiology Center (TEC) followed by a summer
internship. Student research projects will be a part of their Graduate Research Assistant role
where they will be supported for two semesters followed by a paid summer internship.